New control of oncogene activation in T-cell leukemia

Project Summary/Abstract
Notch1 signaling is an important mediator of stem cell self-renewal and therapeutic resistance, and the most
prevalent oncogene (~60%) in T-cell acute lymphoblastic leukemia (T-ALL) - an aggressive neoplasm of T cell
progenitors that affects both children and adults. Although current intensive chemotherapies can suppress the
disease, they come at the cost of serious side effects and are insufficient to eliminate Notch1-driven leukemic
cells. One in five children and one in two adults with T-ALL do not survive due to either unresponsive or
relapsed disease. Efforts to target oncogenic Notch1 with small-molecule inhibitors have been hampered by
their inherent cytotoxicity. Overcoming these difficulties will require improved understanding of the oncogenic
mechanisms controlled by Notch1 and a better appreciation of the genes and pathways that regulate Notch1-
driven leukemogenesis as potential targets of T-ALL therapy. Through Drosophila studies and the generation
of mouse models for T-ALL, we have discovered that, T-ALL-associated Notch could be degraded by an
unconventional endo-lysosomal module through a physical interaction with the autophagic tumor suppressor
UVRAG, which reshapes Notch activity and resultant Notch-dependent cellular response. Thus, the central
hypothesis of this proposal is that the endo-lysosomal titration of Notch activity by UVRAG represents a unique
mechanism governing Notch1 before proteolytic processing, and that disruption of this regulatory module
impacts T-cell homeostasis and contributes to T-ALL. Specifically, we propose experiments to
comprehensively dissect the molecular mechanism of UVRAG-mediated endo-lysosomal inhibition of Notch1 in
T-ALL. Furthermore, we will elucidate the unequivocal impact of this mechanism on the self-renewal and
stemness of leukemia-initiating cell function in human T-ALL primary samples. Finally, we will use the mouse
models to test the concept that boosting this mechanism could restore Notch homeostasis and achieve
sustained T-ALL remission. These aims will be addressed using multidisciplinary innovative approaches that
integrate state-of-the-art genetic, biochemistry, high-resolution imaging, and physiological assays in cells and
transgenic mouse models. We now bring within this proposal a collaboration of world-wide leaders in T-ALL
pathology and molecular biology along with clinicians and pathologists. Our use of patient-derived T-ALL
samples will maximize the relevance of our findings for eventual translation to T-ALL patients in the clinic.
Overall, this project will lead to an in-depth understanding of Notch1-driven leukemogenesis, and provides a
critical trajectory for the development of optimal anti-leukemia strategies against this aggressive lymphoid
malignancy.

Public health relevance
Project Narrative The proposed research is of high relevance to Public Health, because it aims at understanding and controlling Notch1-driven leukemogenesis and discovering potential new target to guide the personalized treatment of a disease of unmet need. The successful completion of the proposed project will elucidate a new ‘molecular rheostat’ that calibrate Notch signaling activation and open the way for targeting the endo-lysosomal pathway in T-ALL.